Cross-talk of Neurons and HSV-1 during Viral Latency and Reactivation

Project summary and abstract
During a malicious acute infection of epithelial cells, the HSV-1 completed a robust but well-
organized gene expression (approximately 90 unique transcriptional units) in about 18-20 hours.
The viruses then entered the ganglionic neurons through the innervating nerves and attempted
to establish a dormant state of infection (latency). During the latency initiation, the vigorous viral
gene expression is almost completely suppressed with only a few noncoding RNA detected in
host neurons.
We believe the neurons played a key role in the HSV-1 gene silencing and latency establishment.
Previously, we used a rodent dorsal root ganglia (DRG) neuronal model to investigate the
crosstalk between the viral replication and the neuronal discharge during latency and reactivation.
We found that HSV-1 neuronal infection abolished the functional expression of voltage-gated Na+
and Ca2+ channels within hours. The neurons responded to the assault by rescuing the Na+ &
Ca2+ channel expression during the course of latency and established latent reservoir. Induced
viral reactivation would decrease the channel activity and increase viral gene expression.
Elevated neuronal firing, nonetheless, would reduce the viral gene expression and release of
infectious viruses. Therefore, we hypothesize that neuronal excitation offered an environment to
suppress viral replication thus facilitate the establishment and maintenance of latency.
To understand the mechanisms, we developed an in vitro human DRG neuronal model HD10.6,
which mimics the mature neurons for latency and reactivation in human. We showed for the first
time that a human microRNA overexpression facilitate a quiescent state of infection in HD10.6
without the need of replication inhibitor Acyclovir. In this proposal, we will first characterize the
voltage-gated channel activity in HD10.6. Next, we will investigate how virus attacked the
neuronal discharge to facilitate its infection. Finally, we will determine the counteracting schemes
that neurons exploited to repress viral replication and keep the virus in a dormant state from
reactivation.

Public health relevance
PPROJECT NARRATIVE Herpes simplex viruses (HSV) can infect human causing severe neurological damage and painful orofacial complications. We will use an innovative method to study the molecular mode of action of HSV infection of neurons. Success of this proposal will set the basis for a better understanding of racial and gender disparities post viral infection.